Determinants of transitioning from injecting to smoking fentanyl and methamphetamine and implications for harm reduction implementation

PROJECT SUMMARY/ABSTRACT
The proposed R36 dissertation research project will identify trends and multilevel determinants of
transitioning from injecting to smoking drugs (predominantly fentanyl and methamphetamine) in the San Diego-
Tijuana border region to inform service delivery for people who use drugs (PWUD). People who inject drugs
(PWID) face a high burden of overdose and infectious diseases (e.g., HIV, viral Hepatitis), especially in the
border region where binational disease transmission and drug trafficking create challenges for prevention
efforts. Some PWID in California, including San Diego, have recently shifted to smoking instead of injecting
opioids. Many syringe services programs (SSPs) offer safer smoking supplies (e.g., glass pipes, silicone
mouthpieces), the use of which has been linked to reduced sharing of injection and smoking equipment and
the use of ‘make-shift’ supplies like plastic bottles. However, some SSPs are struggling to meet the already
high and increasing demand for safer smoking supplies, especially in resource-constrained settings like
Mexico. We will use a Social Ecological Model-enhanced Exploration, Preparation, Implementation, and
Sustainment (SEM-EPIS) framework to identify individual- (e.g., overdose experience), interpersonal- (e.g.,
peer norms), community- (e.g., access to SSP services), and structural-level (e.g., city policy) determinants of
transitioning from injecting to smoking heroin, fentanyl, and methamphetamine and examine internal (i.e., SSP)
and external (e.g., local public health and law enforcement factors) implementation considerations for
distributing safer smoking supplies. Using an explanatory sequential mixed-methods approach guided by SEM-
EPIS, this dissertation will meet the following specific aims: Aim 1: (a) examine the extent to which people who
inject heroin, fentanyl, and methamphetamine are transitioning to smoking and (b) identify the multilevel
determinants of these transitions; Aim 2: explore experiences with and perspectives on multilevel determinants
of transitioning from injecting to smoking among PWUD, including the use of safer smoking supplies; and Aim
3: investigate the internal (i.e., SSPs) and external implementation considerations for distributing safer smoking
supplies in the San Diego-Tijuana border region. We will leverage the ongoing binational La Frontera cohort
study (R01DA049644; n=612) and use latent transition analysis to identify PWUD with respect to patterns in
the frequency (low vs. high) of injection and smoking over time and multilevel determinants of these transitions
(Aim 1). We will then purposively sample ~30 PWUD and ~25 internal (i.e., SSP staff) and external key
informants (e.g., public health officials) to participate in Aim 2 and 3 qualitative interviews to further
contextualize and expand upon findings from Aim 1. Our proposed study will provide context around substance
use trajectories for PWID to enhance the implementation and scale-up of safer smoking supplies at a time
when evidence-based strategies are urgently needed to address the rising harms of injection drug use.

Public health relevance
PROJECT NARRATIVE This R36 dissertation study examines transitions from injecting to smoking drugs (predominantly fentanyl and methamphetamine) among people who inject drugs (PWID) in the San Diego- Tijuana border region. Such transitions may help reduce infectious disease (e.g., HIV, HCV) and overdose morbidity and mortality if sufficient quantities of safer smoking supplies are accessible (e.g., through syringe service programs; SSPs). By examining the multilevel (e.g., individual, organizational, structural) factors driving these transitions in drug consumption patterns and related implementation considerations for distributing safer smoking supplies through SSPs, this project will inform efforts to improve the delivery of prevention services and reduce the high burden of infectious diseases and overdose among people who use drugs.